Health Consequences of Workplace Policies/Practices-CC

[unreadable] DESCRIPTION (provided by applicant): The past 50 years have seen fundamental changes in the workplace. These changes have increased the demands and stress placed on workers, their families, and their dependents. As men and women attempt to balance work and family demands, employers are enacting policies that have both positive and negative impacts on work-life balance. The Workplace Health Policies and Practices Network will conduct research to improve employees' abilities to successfully meet work and family demands, thereby improving worker and family health and well-being. This application is for a Coordinating Center that will support the Network. [unreadable] [unreadable] The Center for Health Research (CHR), as the Network's Coordinating Center (CC), will develop a Network infrastructure allowing researchers to conceptualize, design, pilot, and execute innovative models of workplace policies and practices for improving health and well-being of workers, their spouses, and their dependents. The CC will develop and implement communication systems among Network partners, arrange logistics for Network activities, serve as a data and methods repository for Network research products, and facilitate results dissemination and translation. CHR also offers expertise in estimating return on investment (R0I) of workplace policies and practices and expertise in work- and health-related interventions. [unreadable] [unreadable] [unreadable]